Targeting Isoform-specific FGFR Signaling in Idiopathic Pulmonary Fibrosis

ABSTRACT
Idiopathic Pulmonary Fibrosis (IPF) is a chronic, progressive lung disease predominantly affecting older adults,
with most diagnoses occurring in individuals over 65. Treatment options for IPF are limited, and existing
medications focus on slowing disease progression rather than providing a cure. This underscores the need for
detailed studies of the disease's root causes and the development of strategies to target specific pathways for
safe and effective treatment. The fibroblast growth factor receptor (FGFR) signaling pathway is implicated in the
pathogenesis of IPF; however, the exact mechanism by which FGFR signaling contributes to pulmonary fibrosis
remains unclear. We hypothesize that the activities of the mesenchymal c-isoform and the epithelial b-isoform
of FGFR play distinct roles in the pathogenesis of pulmonary fibrosis and that modulating the isoform-specific
activities of FGFR could potentially provide an effective means to alleviate pulmonary fibrosis. The aims of this
proposal seek to address this overall hypothesis by (1) conducting comprehensive in vitro studies of FGFR
isoform-specific signalings in primary lung cells, and (2) establishing the effects of modulating FGFR isoform-
specific signaling in an animal model of pulmonary fibrosis. The outcome of the proposed studies will provide
the enhanced understanding of FGFR signaling in pulmonary fibrosis and offer novel therapeutic avenues for
the treatment of IPF.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to the public health because it aims to understand the basic mechanism of how fibroblast growth factor receptor (FGFR) signaling is implicated idiopathic pulmonary fibrosis (IPF), an aging- related chronic disease. We will investigate if modulating FGFR activities can alleviate pulmonary fibrosis process and offer a novel therapeutic strategy for IPF.